Implantable, Degradable Drug Delivery Devices for Non-Opioid Post-Surgical Pain Management

One out of every nine Americans has surgery each year and 30-80% experience uncontrolled postoperative
pain. There is a clear need to 1) localize treatment to simplify delivery and avoid systemic toxicity, 2) achieve
long duration release to span the duration of postoperative pain without the need for opioids, and 3) deliver
adequate pain control customized to the patient and the location of pain. This R18 HEAL research offers the
opportunity to transform postoperative pain control using a new device: a biomaterial film to deliver local
anesthetics after surgery. Our device is flexible, can be cut for precise dosing, is sutured in place during surgery,
and degrades when no longer needed. It can be placed intraoperatively in multiple locations to target nerve
locations and, unlike liquid formulations, it will not migrate. Our device can be used by adults, but includes design
features that allow it to be “right-sized” for infants and children. The surfaces of the biocompatible, biodegradable
protein films have a dense "lawn" of brush polymers that are linked via a tethering molecule to the anesthetic
ropivacaine. The films feature two modes to control drug release by modifying 1) diffusion through the brush
polymer layer and 2) the susceptibility of the tethers to hydrolysis, the combination of which are hypothesized to
permit controlled continuous release of ropivacaine at the desired site. Aim 1 will synthesize protein films
conjugated with brush polymers that are hydrophilic, hydrophobic, or intermediate in nature that are linked to
ropivacaine by a tether of varying composition and will measure the release of ropivacaine in different in vitro
environments that mimic the human body. This aim will also characterize the release of ropivacaine from the
polymer brushes with different brush spatial arrangements. Aim 2 will assess the safety and efficacy of the film.
First, it will be evaluated with in vitro cell viability and in vivo by histological evaluation for local tissue inflammation
and film degradation. Plasma concentrations of drug released from implanted films will be quantified in a
catheterized rat model, and pharmacokinetic modeling will be used to establish a local in vivo drug release curve
as well as to correlate in vitro and in vivo release. Finally, the efficacy of the film to block nerves in vivo and to
reduce pain in vivo in mice after surgery will be evaluated along with the local tissue response to the implanted
biomaterial. Aim 3 will address the unique requirements of the HEAL RFA, with customer discovery, market
research, and manufacturing partnership and FDA meetings as needed to prepare for first-in-human trials. This
novel brush polymer technique, never before used for drug delivery, offers the unprecedented opportunity to
solve the critical limitations of local anesthetics and provide “right-size”, continuous, opioid-free postoperative
pain control to patients.

Public health relevance
RELEVANCE TO PUBLIC HEALTH One out of every nine Americans has surgery each year, and up to 80% experience uncontrolled postoperative pain due to the inadequacies of current pain control therapies that put children at risk of long-term chronic pain and adults at risk of complications and opioid abuse. Sustained delivery of a non-addictive anesthetic at the surgical site could treat postoperative pain without the need for opioids, but current formulations and delivery methods do not last as long as patients feel pain after surgery. Our work will develop a new class of biocompatible, biodegradable film devices that can be implanted at the time of surgery, deliver local anesthetic directly to the surgical site for seven days, and ultimately degrade when no longer needed.